Career Enhancement Program

PROJECT SUMMARY
The NYU Melanoma SPORE Career Enhancement Program (CEP) will prepare investigators for independent
translational research careers to study melanoma. To accomplish this goal, the CEP will select, support, and
guide individuals focused on becoming leading translational researchers in melanoma. The Director of the
CEP, Dr. Seth Orlow, Chairman of the Department of Dermatology at NYU Langone Health (NYULH), has an
established track record of success in training translational scientists. The NYU Melanoma SPORE CEP will
support outstanding candidates for up to 2 full years by providing both financial assistance and academic
guidance. This will enable awardees to establish successful investigations related to melanoma, and
simultaneously provide a solid foundation to further develop full research projects within the SPORE. The CEP
will nurture and grow the pipeline of talent in melanoma translational research by recruiting and supporting
promising junior or rising faculty in addition to more established investigators with the potential to become
accomplished independent investigators focused on melanoma translational research. The CEP will monitor,
oversee, and mentor each individual chosen for the CEP to ensure the investigator’s progress towards a
successful independent career in melanoma translational research, in addition to availing awardees to
programs and collaborations to build the skills necessary to achieve this end. The CEP is strongly committed to
training women and underrepresented minority candidates at all levels for careers as independent
investigators. Unique strengths that will be beneficial to CEP awardees include existing formal coursework
offered by NYU that leads to a Master of Science degree in translational research and a large pool of
accomplished mentors across multiple specialties. The CEP is thematically aligned to the NYU Melanoma
SPORE’s overarching mission to use personalized biomarkers to optimize clinical management of melanoma
patients, and is highly integrated with the programs and projects of the SPORE. This thematic integration will
enable the CEP to maximize the progress of the awardees careers.

Public health relevance
PROJECT NARRATIVE The Career Enhancement Program (CEP) will drive the NYU Melanoma SPORE’s efforts to recruit and mentor individuals who can advance translational research on melanoma. The multifaceted support of promising melanoma translational research candidates, with a focus on women and underrepresented minorities, will further the SPORE’s primary mission to optimize the clinical management of melanoma patients at the greatest risk of disease progression or death.